Increasing Medicaid Acquisition and Sustainment among the Uninsured

ABSTRACT
Uninsured patients are subject to catastrophic health expenditures, have higher rates of mortality, and far more
limited access to important healthcare resources (e.g., preventative or specialist care, rehabilitation, mental
health) compared to insured patients. Uninsured individuals often defer care until treatment is urgently
required, which can lead to debilitating disease, job loss and high medical bills. With more than 70% of
uninsured patients unable to pay for their healthcare, U.S. hospitals and states are left to bear the brunt of
uncompensated care ($42 billion). Hospital Presumptive Eligibility (HPE), a hospital-based emergency
Medicaid program, is a successful solution to these problems. Patients enroll in temporary HPE healthcare
coverage (up to 60 days), with an opportunity to sustain insurance by applying for Medicaid full coverage.
Although HPE is a national Medicaid requirement, California is among the more inclusive in terms of HPE
eligibility. Among the 31 million remaining uninsured Americans, 10% are in California, the world’s 5th largest
economy.
During our previously funded R21 through the NIMHD, we collaborated with the California Department of
Healthcare Services (DHCS) to create an innovative new dataset that tracks HPE enrollees across the state
and follows them longitudinally to evaluate for Medicaid sustainment. Over 100,000 previously uninsured
Californians enroll in HPE annually, up to 64% of whom sustain Medicaid at six-months. Inpatients, those
requiring surgery or post-discharge health services are more likely to sustain insurance, with minority groups
less likely to sustain. Across hospitals, Medicaid sustainment ranges from 33-97%. Our preliminary data
suggests that patient socio demographics, availability and training of hospital personnel and county-level
engagement contribute to success of Medicaid sustainment after HPE enrollment. In response to PAR-20-310,
investigation of modifiable predictors of Medicaid sustainment will guide our development of a DHCS, hospital
and county-stakeholder informed “best practice” toolkit intervention for dissemination across hospitals, with the
goal of increasing reducing insurance-based disparities.
We will pursue 3 specific aims: (SA1) quantitatively characterize distribution of sustainment across hospitals
and identify patient and hospital-level factors associated with Medicaid sustainment after HPE, (SA2)
qualitatively identify hospital and county practices that promote or limit success Medicaid sustainment across
diverse settings, and (SA3) develop a stakeholder-informed best practice “toolkit” aimed at increasing Medicaid
sustainment across hospitals and counties.
Our goal by developing strategies for increasing sustained insurance coverage is to improve access to care,
clinical outcomes and financial health among disadvantaged and uninsured patients.

Public health relevance
PROJECT NARRATIVE The time of hospitalization is an under-utilized opportunity for intervention, whereby uninsured patients can obtain sustainable Medicaid insurance coverage through Hospital Presumptive Eligibility (HPE) programs which can in turn improve patients’ long-term healthcare access, clinical outcomes, and financial health. Our prior NIMHD-funded R21 work identified modifiable patient and system level barriers, amplified in minority groups, that inhibit successful Medicaid sustainment after HPE approval. Our current proposal involves mixed- methods analysis of these factors to guide development of a stakeholder-informed toolkit providing hospitals and county policy-makers with evidence-based strategies to reduce insurance-based disparities at the clinical point of care, particularly among minority racial and ethnic groups.